Developmental Research Program

Modified Project Summary/Abstract Section
The Developmental Research Program (DRP) is an essential component of the SPORE and critical to the longterm fight against ovarian cancer. It provides an avenue for soliciting new research ideas and for developing
innovative, high-risk, but high-impact projects to stimulate ovarian cancer research in the context of the SPORE.
Pilot studies provide investigators with the resources to conduct translational research consistent with the
SPORE’s objectives. The selection process will be made by the DRP Scientific Review Committee, which is
composed of accomplished investigators who have demonstrated outstanding track records in cancer research.
The recipients will be required to submit annual progress report(s) that the committee will review. This Program
encourages participation from a broad range of investigators at Johns Hopkins University (JHU), the University
of Pennsylvania (PENN), and the Wistar Institute by providing support for pilot projects with the potential to
develop into more fully developed translational projects. It also encourages and facilitates the development of
new research directions, methodologies, and collaborations. In addition, a combined total of $250,000 annually
is available from the institutional match funds together with the SPORE support to fund as many as 5-7 projects
at the funding level of $40,000-$50,000 per year.
Specific Goals
• To provide initial funds for novel explorations related to translational ovarian cancer studies.
• To integrate the awardee into the SPORE community by participation in monthly meetings, group
communications, and opportunities for expanded funding and collaborations.
• To review progress and recommend avenues for the continuation of successful projects.

Public health relevance
Modified Public Health Relevance Section The relevance of this Developmental Research Program to public health is to enhance the awareness, early detection, and prevention of ovarian cancer among the population, and to support cutting-edge research that benefits public health.